Elucidating the role of G6PC2 in glucose-regulation of glucagon secretion in pancreatic alpha-cells

Project Summary
Blood glucose homeostasis is a central metabolic challenge in vertebrates and is regulated by the
coordinated action of glucagon-producing α-cells and insulin-producing β -cells within the endocrine pancreas.
Disturbances in this regulatory network cause metabolic disorders such as type 2 diabetes mellitus (T2D) –
whose prevalence, comorbidities, and medical costs constitute a significant public health concern. Although the
defining physiological abnormalities underlying T2D are an inappropriately low insulin secretory response to
elevated glucose levels and insulin resistance, patients with T2D also exhibit hyperglucagonemia which
exacerbates hyperglycemia through stimulation of hepatic glucose production. While mechanisms of glucose-
stimulated insulin secretion have been established, the suppression of glucagon secretion by glucose has
remained poorly understood. Support for a critical role of glycolytic flux in regulating glucagon secretion comes
from a recent study in which α-cell-specific ablation of glucokinase impaired glucose-induced glucagon
suppression. Additionally, the Kaestner lab has found using single cell RNAseq of islets from T2D organ
donors that the islet-specific glucose-6-phosphatase 2 (G6PC2), which opposes the action of glucokinase, is
dramatically upregulated in -cells in T2D patients. This upregulation is functionally important, because
overexpression of G6PC2 in murine pseudo-islets has been demonstrated by the Kaestner lab to increase
glucagon secretion. This research proposal will test the hypothesis that α-cell glycolytic flux mediates glucagon
secretion, and its dysregulation underlies hyperglucagonemia observed in Type 2 Diabetes patients.
The function of G6PC2 in the regulation of glucagon secretion will be investigated in vivo using an
inducible, -cell specific genetic mouse model under normal and diabetogenic conditions. Mice with -cell
specific G6PC2 ablation will be evaluated using glucose tolerance tests to assess glucagon secretion under
varying blood glucose levels in vivo. Pancreatic islets will then be isolated and subjected to both static and
dynamic hormone secretion assays to verify the role of G6PC2 on glucagon secretion ex vivo. Additionally, -
cell-enriched ‘pseudo islets’ will be prepared and analyzed for glycolysis using the Seahorse XFe96 Analyzer
under glucagon stimulating and suppressing conditions to assess the impact of genetic manipulation of G6PC2
levels on -cell glycolytic flux and ATP production rate. To determine how these findings translate to humans,
these studies will also be performed in human  cells via complementary loss- and gain-of-function studies
using the previously described ex vivo hormone secretion and glycolytic rate assays.
Ultimately, the results from study will contribute to our fundamental understanding of -cell biology and
T2D pathophysiology, and identify a potential therapeutic target for improving T2D hyperglucagonemia and
restoring blood glucose homeostasis.

Public health relevance
Project Narrative Blood glucose homeostasis is central to our health, and its failure results in debilitating metabolic diseases such as Type 2 Diabetes (T2D). Although the pathophysiology of T2D is bi-hormonal, with both insufficient insulin production by -cells and elevated glucagon release by -cells, the exact regulation of glucagon release by -cells and its dysregulation in T2D are still not completely understood. With the integration of an -cell specific genetic mouse model, complementary ex vivo studies in murine and human islets, and comprehensive techniques to monitor real-time changes in -cell metabolism and hormone secretion, this study will expand upon our understanding of -cell biology and T2D pathophysiology, as well as identify a putative therapeutic target for mitigating T2D hyperglucagonemia and restoring glycemic control.